Deciphering Statin-Induced Muscle Symptoms: Mechanisms and Therapeutic Insights

Project Summary
Statin therapy is widely prescribed for the management of cardiovascular diseases, yet statin-associated muscle
symptoms (SAMSs) frequently lead to therapy discontinuation. Our study aims to elucidate the underlying
mechanisms of SAMSs and explore potential therapeutic interventions. We hypothesize that statin-induced
muscle weakness is mediated through ryanodine receptor 1 (RyR1) calcium leakage, exacerbated by the RyR1-
T4706M mutation. We have access to muscle tissue and other samples from a patient who carries this RyR1-
T4706M mutation and is profoundly intolerant of all statins. We further have a mouse model based on this
patient’s genotype. Using cryo-electron microscopy, electrophysiological recordings, in vitro assays, and genetic
mouse models, we will identify the binding sites of commonly used statins on RyR1, evaluate their effects on
muscle function, and assess the potential benefits of RyR1 stabilization with ARM210 in preventing statin-
induced muscle weakness. This research holds promise for identifying novel therapeutic strategies to mitigate
SAMSs and improve patient tolerance of statin therapy.

Public health relevance
Project Narrative Our study seeks to uncover the mechanisms underlying statin-associated muscle symptoms (SAMSs) and explore therapeutic interventions to alleviate this common side effect of cardiovascular therapy. By investigating the role of ryanodine receptor 1 (RyR1) calcium leakage, particularly in the context of the RyR1-T4706M mutation, we aim to elucidate the molecular basis of statin-induced muscle weakness. Through a comprehensive approach combining cryo-electron microscopy, electrophysiological recordings, and genetic mouse models, we strive to identify potential therapeutic targets and enhance patient tolerance and adherence to statin therapy, ultimately improving cardiovascular outcomes.